Descending engagement of brainstem neuronal circuits that govern orofacial motor behaviors

PROJECT SUMMARY
I propose to investigate the neuronal control of orofacial behaviors in rodents. Orofacial behaviors in mature
rodents include ingestive behaviors such as licking and chewing, as well as exploratory behaviors, such as
sweeping movements of the facial whiskers, or “whisking”, sniffing, and directed nose and head movements.
Infants engage in suckling behavior, which involves both exploratory nipple-seeking movements and ingestive
sucking movements. The mammalian brainstem contains networks of neurons that control all of these orofacial
behaviors, and these networks are directed by other, more rostral parts of the brain that ensure that the
associated behaviors are executed in the appropriate context; that is, when the appropriate environmental and
internal sensory cues are present. I intend to investigate how these higher-order brain areas influence the
appropriate brainstem network modules to implement the animals’ decision to execute an appropriate orofacial
motor act.
In the mentored phase of the project, I will focus on identifying the neuronal circuit mechanisms that
underlie suckling behavior in newborn mice, a topic which, despite its importance for mammalian survival, has
been largely ignored by neuroscientists in recent years. To identify neuronal cell-types that are active during
suckling, I have been measuring the co-expression of immediate-early-genes along with cell-type specific
molecular markers. I can then use the identified neuronal cell-type markers as genetic entry-points to trace the
neuronal circuits they comprise. At the same time, I have been developing new viral vector tools to rapidly
deliver modern molecular tracers and actuators to the early postnatal mouse brain to probe the mechanisms by
which these neuronal circuits code suckling behavior. During the award period, I will use these new tools to (1)
map the input/output connectivity of identified suckling-active neuronal populations, and (2) manipulate the
activity of these populations in-vivo to determine their roles in generating and maintaining suckling behavior. In
the independent phase I will extend my focus to the broader repertoire of ingestive and exploratory orofacial
behaviors in adult mice, with the goal of understanding (3) how forebrain inputs to brainstem orofacial pre-
motoneurons may gate the expression of these behaviors depending on the environmental and motivational
context. Investigating the brainstem modules for such innate motor acts represent an ideal model for studying
how networks of connected neurons in the brain control simple behaviors and how nervous systems make
decisions.
The mentored phase of the project, conducted under the direction of Dr. Catherine Dulac at Harvard
University and Dr. Samuel Pfaff at the Salk Institute, outlines a comprehensive plan for the acquisition of a
unique combination of technical and professional skills that will enable my transition to an independent
research position.

Public health relevance
PROJECT NARRATIVE The brainstem controls life-sustaining orofacial movements, including suckling, chewing, swallowing, and airway patency, and determining the neuronal circuit mechanisms that regulate these behaviors can provide crucial information to understand more general mechanisms of brain function. Additionally, deficits in orofacial control and the return of primitive oral reflexes in adults, including rooting and suckling, are prominent symptoms of neurodegenerative disease, such as Parkinson’s disease and vascular dementia. Understanding how these behaviors are controlled in the healthy brain can help to identify the cause of these pathologies and how to treat them.